Linking pre- and post-natal psychosocial determinants, DNA methylation, and early developmental health disparities

PROJECT SUMMARY Despite improvements in access and quality of health care in the United States (US), children from socioeconomically disadvantaged families and / or of minority race have an elevated risk for impaired cognitive and social-emotional development. Disparities in child development are now indicated as the origins for many adult diseases. Indeed, children in poverty are 40% more likely to experience developmental delays relative to children not in poverty. Poverty engenders disproportionate exposure to adversity including parental/child psychosocial stressors (such as, violence, relocation, and food insecurity) and psychological distress (such as, maternal depression) that contribute to impaired childhood development. However, negative effects may be mitigated in the presence of protective factors. While measures of maternal adversity and protective factors have been evaluated in association with child development, the combined effects of these opposing forces and the potentially related and critical role of epigenetic programming have not been determined. In particular, at sensitive periods across the life-course when their effects have the strongest impact. Our preliminary data suggest that maternal adversity during two sensitive time periods (prenatally and early life) epigenetically program infant response systems, thereby altering child development. Our overall hypothesis is that maternal adversity and protective factors (i.e., maternal psychosocial experience) faced across the life-course contribute to offspring cognitive and social-emotional developmental disparities through DNA methylation (DNAm) of genes in multiple biologic pathways. This study combines retrospective assessment and prospective data collection on 375 mother-infant dyads captured in 5 study visits spanning pregnancy through 18 months postnatal. The specific aims of the proposal are 1) determine the association between the life-course maternal psychosocial experience and the change in infant DNAm during the first year of life, a sensitive developmental window, 2) characterize the association between postnatal maternal psychosocial experiences in the infant’s first year of life and infant DNAm at one year, and 3) determine the impact of DNAm at two time points (1 month and 12 months) of infant development across the first 18 months. This research will be conducted within a large, regional home visiting program, uniquely positioning us to translate findings through precision home visiting and additional strategies aimed at reducing early developmental health disparities.

Public health relevance
PROJECT NARRATIVE PUBLIC HEALTH RELEVANCE: Maternal psychosocial exposures across the life-course contribute to infant development; however, the combined effect of adverse and protective factors and the sensitive windows when factors have the greatest impact, has not been elucidated. This proposal will determine the contribution of opposing forces of adversity and protective factors to multiple measures of DNA methylation and infant development. Completed within a large home-visiting program, results will inform home visiting practice and may be generalizable to more broadly to additional early intervention programs aimed at reducing developmental disparities